Utilizing patient-derived premalignant colon organoid biobank to interrogate existing and novel chemoprevention strategies

Chemoprevention is an important, but challenging field of study due to the lack of pre-cancer model systems for
research studies. Familial adenomatous polyposis (FAP), a hereditary condition characterized by polyp formation
and a high risk of cancer development, has been the focus of tens of chemoprevention clinical trials all
investigating the same target, cyclooxygenase-2 (COX-2). However, due to inconsistent efficacy across studies
and significant off-target effects, no agent is currently recommended for FAP chemoprevention. Furthermore,
there is limited research on why these agents have failed, leaving a critical gap in understanding that needs to
be addressed in order to guide the development of more effective therapeutic strategies. This proposal aims to
better understand how signaling and metabolic pathways are altered in premalignant polyps in effort to design
more targeted and effective treatments for FAP patients. To facilitate this goal, I have generated a biobank of
normal and premalignant organoid samples derived from extensive multi-sampling of individual patients,
capturing both inter-polyp and inter-patient heterogeneity. From this, I discovered that polyp organoids derived
from the same patient display variable growth rates and differing responses to two COX-2 inhibitors, which could
not be rescued by the downstream primary effector PGE2. Moreover, I found polyp organoids exhibit altered
metabolism beyond COX-2, which I hypothesize is indicative of a broader metabolic reprogramming that can be
explored for future chemoprevention strategies. With the advisory of a team of expert scientists in single cell
analyses, proteomics, metabolomics, and CRISPR screens, techniques I will add to my skillset following
completion of this proposal, I plan to uncover the mechanisms underlying polyp variable response to COX-2
inhibitors and explore novel metabolic strategies for chemoprevention. In Aim 1 I will investigate the mechanisms
of resistance in polyp organoids that show poor responses to COX-2 inhibitors, with the goal of identifying
combination therapies to lower toxicity. In Aim 2, I will investigate the mechanisms of COX-2 sensitivity by
examining how COX-2 signaling and downstream eicosanoid molecules regulate the activation of signaling
cascades that influence cell growth and cell state. Finally, Aim 3 will move beyond COX-2 signaling to identify
new metabolic pathways driving cell growth in polyps, providing insight into pre-cancer metabolic rewiring and
offering potential new therapeutic strategies. Ultimately, this research has the potential to uncover novel
therapeutic strategies that can significantly improve the effectiveness of chemoprevention in FAP patients and
pave the way for broader applications in the prevention of sporadic colorectal cancer.

Public health relevance
This study aims to improve human health by identifying new ways to prevent the development of colorectal cancer in patients with familial adenomatous polyposis, a genetic condition that greatly increases cancer risk, with potential broader implications for sporadic colorectal cancer. By using advanced technologies and highly relevant patient-derived models, this project will uncover why current treatments in patients vary in effectiveness and what new strategies are likely to succeed. Ultimately, this research could lead to more effective therapies, reducing the need for invasive surgeries and improving long-term outcomes for patients.